Partnership for Research in Emerging Viral Infections-Sierra Leone (PREVSL)

Project Summary/ Abstract: Our existing award titled: Partnership for Research in Emerging Viral
Infections-Sierra Leone, (PREVSL) [pronounced “Prev Sil”] (currently in its fifth year) has successfully begun
to lay the foundation for Sierra Leone led implementation science and clinical trial research in emerging infections
through capacity strengthening activities that targeted both the Kenema Government Hospital (KGH), a long-
standing international field research site for the Viral Hemorrhagic Fever research program, located in the
country´s Eastern Province; and the College of Medicine and Allied Health Sciences (COMAHS) at University of
Sierra Leone (USL) in the capital city of Freetown, the country’s only medical school.
Emerging infections threaten the health of people, animals, and agriculture but our systems for surveillance and
detection are limited. Emerging infections are defined as those that have recently appeared in a population or
that previously existed but have recently increased in incidence or geographic scope, such as was seen with the
recent Mpox outbreak.
Africa, and in particular West Africa, has a disproportionate vulnerability to outbreaks due to the large number of
zoonotic reservoirs, poor healthcare infrastructure, and the high number of endemic infectious diseases found
there. In Sierra Leone alone, EVD, Lassa Fever, Crimean Congo Hemorrhagic Fever, Yellow Fever, Dengue,
Chikungunya, Mpox, Influenza, and SARS-CoV-2 have all been identified there. In addition, bat populations
common to Sierra Leone have been found to have Marburg virus. Finally, like much of Africa, Sierra Leone also
has high rates of antimicrobial resistance.
With the foundations established in Phase I of PREVSL now in place, we will shift the bulk of our focus in the
renewal proposal towards COMAHS, ensuring it has the capacity to train the next generation of high quality
biomedical and public health scientists AND that it maximizes its potential to be a major player in driving Sierra
Leone´s infectious disease research agenda. We will do this while continuing to strengthen the KGH clinical
research program as a training site for future COMAHS masters and doctoral student researchers and through
the promotion of ongoing implementation science and clinical trial research in emerging infections from which
trainees can attain practical and applied research skills and experiences.
Our Specific Aims are to 1) Train four PhD level investigators from Sierra Leone in disciplines relevant to
emerging infectious diseases and pandemic preparedness; 2) Reinforce institutional capacity and
competitiveness of COMAHS as Sierra Leone´s premier academic health sciences research institution; and 3)
Promote and expand the conduct of high-quality implementation science and clinical trial research in emerging
infectious diseases and pandemic preparedness by continuing to capacitate the Kenema Government Hospital
- clinical research program field site.

Public health relevance
Project Narrative The University of Sierra Leone, College of Medicine and Allied Health Sciences (COMAHS) and Kenema Government Hospital (KGH), in partnership with Tulane University; will build upon successes of its first five-year period to continue developing implementation science and clinical trial research capacity for emerging infections in Sierra Leone. The overarching five-year goal of the PREVSL project, in Phase II, will be to provide the support necessary to COMAHS and its newly launched PhD degree program in Biomedical Sciences and Public Health that will anchor effective systems over time and ensure the PhD programs long-term sustainability. We will do this while continuing to strengthen the KGH clinical research program as a training site for future student and researchers through the promotion of ongoing implementation science and clinical trial research in emerging infections from which trainees can attain practical and applied research skills.